The role of epigenetic modifiers in regulating the developmental plasticity of cranial neural crest cells

Summary
How stem progenitor cells maintain plasticity for proper cell fate determination over developmental time is a
fundamental question in developmental biology and regenerative medicine. Cranial neural crest cells (cNCCs)
are an excellent example of a well defined cellular lineage transition in which multipotent cells step through a
series of more restricted progenitors to give rise to diverse array of differentiated cell types, including neurons
and glia of the peripheral nervous system as well as craniofacial cartilage and bone. Thus, understanding the
genetic and epigenetic regulators in cNCC development is key to understanding how cell fate is determined as
well as how cells can be reprogrammed. We hypothesize that the cNCC cartilage/neuron/glial progenitor
retains plasticity through developmental time and cNCC fate acquisition is controlled by regulation of
chromatin accessibility by prdm3. The rationale for the proposed studies is that an in-depth understanding
of the specific factors involved in cNCC lineage transitions will provide insights into both normal developmental
plasticity of cNCCs as well as how progenitors can be reprogramed for tissue repair. We will test this
hypothesis in the following specific aims: 1) Test the hypothesis that prdm3 acts as a molecular cell fate
switch during cNCC differentiation. Here we will test the hypothesis that prdm3 activity is required in cNCCs
cell autonomously to promote the temporal recruitment of progenitors to cartilage by repressing neuronal cell
fate. 2) Test the hypothesis that the cartilage/neuronal/glial (CNG) progenitor retains plasticity through
developmental time and can be reprogramed by loss of prdm3. In Aim 2, hypothesis that CNG
progenitors retain plasticity over developmental time and into larval stages and are reprogramed with loss of
prdm3. 3) Test the hypothesis that Prdm3 regulates the timing of cNCC differentiation by controlling of
genomic accessibility. In Aim 3, we will test the hypothesis that loss of Prdm3 leads to global alterations in
chromatin state at cNCC progenitor genes, which in turn controls the timing of differentiation. Together, these
studies will reveal basic information of how cNCCs differentiate into specific cell types during development.
The results of this proposal have the potential to reveal important new insights into normal developmental
plasticity of cNCCs such that tissue reprograming can be developed for the repair of damaged craniofacial
tissues.

Public health relevance
Narrative The proposed research is relevant to public health because understanding the mechanism of neural crest cell fate determination is expected to deepen our understanding of the formation of these cells, informing the etiology of neural crest derived congenital birth defects. Thus, the proposed research is relevant to the part of the NIH mission that pertains to developing a fundamental knowledge that will help reduce the burdens of human disability.